Advancing Science, Practice, Programming and Policy in Research Translation for Children's Environment Health (Asp3ire)

OVERALL CENTER
PROJECT SUMMARY
The Oregon State University Center for Advancing Science, Practice, Programming and Policy in
Research Translation for Children’s Environmental Center (ASP3IRE Center) will accelerate the
translation of children’s environmental health research. Drawing upon best practices in translational
science, the ASP3IRE Center will provide infrastructure, training opportunities, data science tools,
stakeholder engagement, and time-sensitive pilot grants to support the development and
dissemination of evidence-informed interventions that protect children from environmental hazards
where they live, go to school, and play. The Center will be able to rapidly identify and prioritize local
areas that would benefit from children’s environmental health (CEH) interventions by creating novel
data science surveillance tools that strategically mine social media feeds and existing environmental
health tracking and health care utilization databases that are produced by our partners at Oregon
Health Authority and Coordinated Care Organizations. Our Center will also leverage the strengths of
the Hallie Ford Center for Healthy Children and Families, the Oregon State University (OSU) Center
for Health Innovation, Coordinated Care Organizations, and OSU’s Extension Services to expand the
network of researchers and practitioners who are able to create, test, evaluate, and deliver evidence-
based interventions where they are needed the most. These unique resources will make Oregon a
“living laboratory” for the development and delivery of evidence-based CEH interventions for the
broader scientific community and help advance the field of children’s environmental health research
translation that promote diversity, equity, and inclusion. Finally, the ASP3IRE Center will create an
online portal that will serve as a searchable repository for comprehensive evidence-based CEH
intervention implementation plans that can be adapted by researchers and practitioners to local
communities across the nation.

Public health relevance
PROJECT NARRATIVE The Oregon State University Center for Advancing Science, Practice, Programming and Policy in Research Translation for Children's Environmental Center (ASP3IRE Center) seeks to close this “environmental health gap” by bridging the fields of health promotion and environmental health science. By following best practices of implementation and dissemination science, the research and activities in this Center will accelerate the uptake of evidence-based interventions that will target children's environmental health issues in in high-risk populations.